Native Alzheimer Disease Resource Center for Minority Aging Research (NAD-RCMAR)

ABSTRACT – Analysis Core
Healthy People 2030, a decennial public health roadmap set by the US Department of Health and Human
Services, calls for public health research and policy focused on improving health equity, with key objectives
related to social determinants of health, including resilience against negative health outcomes. Despite prior
Healthy People objectives to address health disparities among different racial/ethnic groups, the conditions of
birth, learning, labor, and aging continue to unduly influence health outcomes, further exacerbated by prevalent
socioeconomic inequities. Disparities affecting American Indians and Alaska Natives (AI/AN) and Native
Hawaiians/Pacific Islanders (NHPI) are exceptionally persistent, and are especially problematic in diseases of
aging, such as Alzheimer’s disease and related dementias (ADRD). A key knowledge gap is that methods to
identify, diagnose, and risk stratify patients have not been adapted for use in AI/AN and NHPI, who have unique
social, environmental, and access pressures influencing ADRD prevalence, diagnosis, and characterization.
Thus, specific approaches for studying ADRD in AI/AN and NHPI are urgently needed. This Native Alzheimer’s
Disease Resource Center in Minority Aging Research (NAD-RCMAR) is well positioned to enable early-stage
investigators to conduct impactful Pilot Studies on ADRD risk and resilience factors in AI/AN and NHPI, by using
mentoring and structured analytic techniques designed to yield strong conclusions and serve as preliminary data
for grant proposals. The NAD-RCMAR Analysis Core (AnC) is structured to emphasize methods training,
mentoring, and support in ADRD research affecting AI/AN and NHPI populations. Our AnC is well positioned to
support NAD-RCMAR Scientists with methods mentoring and biostatistics support for Pilot Studies; methods
consultation for grant writing; partner with other NAD-RCMAR components to provide didactic instruction; and
develop a research resource of datasets focused on ADRD risk and resilience in AI/AN and NHPI. Our Specific
Aims are to (1) Collaborate with Research Education Component (REC) to provide mentoring and didactic
instruction to NAD-RCMAR Scientists, with a focus on methods for data collection and analysis in risk and
resilience of ADRD disparities affecting AI/AN and NHPI; (2) Collaborate with NAD-RCMAR faculty so that NAD-
RCMAR Scientists can design, conduct, analyze and interpret high-quality research on risk and resilience
disparities in ADRD among AI/AN and NHPI; (3) Provide structured support to NAD-RCMAR Scientists in data
management, analysis, and inference; (4) Maintain and develop a database of studies with data on ADRD risk
and resilience in AI/AN and NHPI; and (5) Work with RCMAR Coordinating Center to share data and information.
Overall, this AnC will help NAD-RCMAR Scientists to maximize scientific rigor while accommodating logistical
and methodological challenges in studying ADRD in AI/AN and NHPI. Our overarching goal is to optimize the
quality of research publications and grant proposals produced by NAD-RCMAR Scientists, to prepare them for
independent contribution and success in a rapidly expanding field of research.